Magnetoelastic Vascular Grafts

PROJECT SUMMARY
Vascular grafts, which are used to replace, bypass, or repair diseased blood vessels in approximately 3 million
surgeries each year, play a crucial role in various medical procedures. However, stenosis remains a significant
issue of post-implantation, with nearly 40% of grafts experiencing reduced patency within 2 years. This high
incidence of stenosis and its life-threatening complications highlight the urgent need for continuous monitoring
of vascular graft patency. However, existing imaging methods for assessing vascular graft stenosis, including X-
ray angiography, magnetic resonance imaging, and Doppler ultrasound, are unsuitable for continuous
monitoring due to their dependence on operator-controlled equipment, invasive contrast agents, and/or
exposure to ionizing radiation. Vascular graft stenosis often goes undetected until it progresses to complete
occlusion, necessitating repeat surgeries. To address this grand challenge, we propose a magnetoelastic
vascular graft (MVG) as a transformative platform technology that not only restores blood flow but also enables
wireless, real-time, and continuous stenosis diagnosis. Our proposed MVG directly translates hemodynamics
into high-fidelity electrical signals, which can be wirelessly transmitted outside the human body. As stenosis
changes the hemodynamics by restricting blood flow, further analyzing these received signals by using artificial
intelligence (AI) can enable continuous and accurate patency monitoring and timely postoperative complication
management. Moreover, the MVG’s hemodynamics-driven working mechanism eliminates the need for
external power or frequent interventions, enabling continuous, real-time stenosis monitoring anywhere, anytime.
This innovative platform technology stems from PI’s recent discovery of the giant magnetoelastic effect in soft
matter (Nat. Mater. 2021; Highlighted by Nature). In our preliminary studies, we successfully fabricated MVGs
with scalability and customizability and validated their biocompatibility and stenosis diagnosis capability in both
rat and swine models in vivo. To further test our hypothesis, three specific aims are proposed for this R01
Research Project: Aim 1) To optimize the MVG and determine how the degree of stenosis affects sensing
signals. Aim 2) To investigate the long-term biosafety and sensing durability of the MVG in rat models. Aim 3)
To investigate the long-term stenosis monitoring in swine models. To achieve these proposed aims, we have
assembled a multidisciplinary team with complementary expertise, including PI Prof. Jun Chen (Ph.D., leading
expert in soft magnetoelastic bioelectronics), Co-Is Prof. Song Li (Ph.D., expert in vascular tissue engineering),
and Prof. Geoffrey Colby (M.D., Ph.D.,16 years of expertise in open microsurgical and endovascular
treatments), and Prof. Wei Wang (Ph.D., Fellow of ACM, IEEE, clinical big data analysis), and Consultant Prof.
Murray H. Kwon (M.D., MBA, expert cardiothoracic surgeon). Successful deliverables are expected to drive a
transformative shift in vascular disease management, enhancing both quality of life and human longevity.

Public health relevance
PROJECT NARRATIVE The proposed study aims to develop a hemodynamics-driven magnetoelastic vascular graft (MVG) as a transformative platform that not only restores blood flow but also enables wireless, real-time, and continuous monitoring for stenosis. This innovation is expected to drive a paradigm shift in vascular disease management by providing a novel, accessible, and cost-effective solution for continuous postoperative stenosis monitoring. Addressing the needs of millions affected by vascular diseases, this platform technology has the potential to significantly improve quality of life and increase longevity.